ORE - Outreach, Recruitment and Engagement Core

REVISED PROJECT SUMMARY - OUTREACH, RECRUITMENT AND ENGAGEMENT CORE
The Mayo Clinic Alzheimer’s Disease Research Center (ADRC) Outreach, Recruitment, and Engagement
(ORE) Core serves as a bridge between ADRC scientific advances and the needs of study participants,
caregivers, and the communities we serve across two distinct geographical regions in Rochester, MN and
Jacksonville, FL. The ORE Core supports ADRC projects, related studies, and national Alzheimer’s Disease and
Related Disorders initiatives. The primary aim of ORE Core is to engage, recruit, and retain ADRC study
participants from socially underserved and ethnoracially underrepresented groups who are at disproportionate
risk for Multiple Etiology Dementia and dementia-related health disparities. We will focus recruitment efforts
specifically on persons from African American/Black (AA), Hispanic/Latino (HL), and Rural Dwelling (RD)
communities (Aim 1). To accomplish this, we will implement and evaluate innovative methods of community-
based outreach, engagement, and research participation in the communities we serve (Aim 2); advance the
science of diverse recruitment by identifying barriers and evaluating solutions to enhance study enrollment (Aim
3); and engage in dementia care research evaluating novel technology-based solutions to address unmet
caregiver needs (Aim 4). We will assess structural and social determinants of health across all aims and identify
opportunities to ensure ADRC cohorts reflect the communities we study. Our success in achieving Core aims
will be facilitated through collaboration with community partners who will help us understand the needs of
community members. We will partner with ADRC Clinical, Biomarker, Genomics, Neuropathology, and
Digital Innovation Core investigators to help inform the content of educational materials and programs to meet
those needs and engage community advisors to ensure materials and programs are culturally and linguistically
appropriate.